Center for Latino Health Research Opportunities-CLaRO

Project Summary/Abstract
Latino populations in Miami-Dade County (FL) continue to experience health disparities and health inequities.
To address these critical public health issues, a well-trained, community-engaged health disparities workforce
is needed; new cohorts of highly skilled, multidisciplinary health disparities researchers can develop new
knowledge and translate research findings into affected underserved communities. Thus, this application
proposes to expand the health disparities research and training efforts of the Center for Latino Health
Research Opportunities (CLaRO). Over the past 6 six years, the University of Miami (UM) and Florida
International University (FIU) have partnered as CLaRO to reduce and prevent health disparities across the
intersecting syndemic conditions of substance abuse, violence, and HIV/AIDS (i.e., SAVA) affecting vulnerable
Latinos (e.g., seasonal farmworkers, inner city, LGBTQ+ communities). CLaRO’s focus has been to reduce
and prevent health disparities across the intersecting conditions of substance abuse, violence, and HIV/AIDS
(i.e., the SAVA syndemic) in vulnerable Latino sub-groups. The proposed CLaRO will expand our central
theme to include: (a) mental health (i.e., SAVA+MH) disparities affecting underserved Latino communities and
(b) equitable implementation science. CLaRO will train early-stage investigators (ESI) to develop expertise in
equitable implementation science to accelerate implementation efforts of evidence-based interventions
addressing SAVA+MH. We will diversify the health disparities research workforce by training, mentoring, and
supporting ESI, particularly those from underrepresented minority (URM) groups, across the translational
pathway from preintervention and efficacy/effectiveness research to implementation science and practice. We
propose a community-engaged, multidisciplinary, research training and mentorship program that is grounded in
equitable implementation science; meaningful collaborations with community stakeholders will be integrated
into CLaRO activities. We will fund at least 3 new Pilot Projects each year for a total of $300,000 per year. Our
Research Enhancement Program for Pilot Awardees and other ESI at UM and FIU will include (1) training on
scientific topics relevant to the CLaRO theme, project management, and grantsmanship; (2) Equitable
Implementation Science Exemplars Series presentations by established investigators; and (3) Network-
enhancing activities that facilitate a culture of belonging for health disparities researchers. Through CLaRO’s
Community/Scientific Advisory Board, we will integrate key community stakeholders in our investigator
development and research dissemination efforts to ensure that results are translated into practice in affected
communities. CLaRO will leverage existing research, training, and community engagement infrastructure at
UM and FIU, and at associated NIH-funded centers and institutes, to create an environment that continues to
promote scientific innovation, research excellence, career development, and community engagement.

Public health relevance
Overall Project Narrative: The proposed Center for Latino Health Research Opportunities (CLaRO) will conduct and promote community- engaged equitable implementation science career development to prepare Latino and non-Latino early-stage investigators (ESI) to conduct research on substance abuse, violence, HIV/AIDS, and mental health (SAVA+MH) in vulnerable Latino communities in the Miami-Dade County (MDC). CLaRO will contribute to the reduction and eventual elimination of Latino health disparities in MDC by training, mentoring, and supporting the next generation of health disparities scientists.